Elucidation of Assembly and Budding Mechanisms of SARS-CoV-2

Project Summary
Severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) is a novel coronavirus responsible for
the ongoing human pandemic (COVID-19) that has been classed as a Public Health Emergency of International
Concern by the World Health Organization (WHO). There is an urgent demand for SARS-CoV-2 research to
facilitate the development of therapeutics, understand viral replication and pathogenesis, and determine how the
virus spreads from cell-to-cell as well as patient to patient. Coronaviruses such as SARS and MERS are among
the most dangerous pathogens on Earth, with high fatality rates and lack of viable therapeutics or vaccines.
They are classified as category C pathogens by the NIH due to their ease of production and dissemination with
the potential of high morbidity and mortality. Detailed mechanistic studies on the dynamics of SARS-CoV-2
replication and viral shedding (i.e., budding) may inform identification of new drug targets in the viral life cycle
and enrich our understanding of how this zoonotic pathogen utilizes host cell lipids to build the viral lipid envelope.
The Stahelin and Voth laboratories, building on collaborations with each other and specific expertise in
biochemistry, biophysics and computational studies of virus assembly, will use experimental in vitro and cellular
studies integrated with computational analysis to investigate the central hypothesis in this grant: that selective
lipid-protein interactions drive the assembly and budding of the M (membrane) and N (nucleoprotein) of SARS-
CoV-2. In two specific aims, we will (i) determine the cellular and biophysical mechanisms by which SARS-CoV-
2 M form virus particles in silico, in vitro and in human cells and (ii) determine how N lipid binding drives
localization that contributes to formation of new viral particles. These studies will be integrated with structural
biology of M (Browhan laboratory) and N (Ollmann Saphire laboratory) and also be validated with authentic
SARS-CoV-2 in a BSL-3 facility in collaboration with the Kuhn laboratory.
These questions will be studied in a tightly integrated approach using structural and in vitro quantitative
techniques to assess lipid-protein and protein-protein interactions and cellular assays to tease apart the
molecular underpinnings of viral protein interactions necessary for viral budding and infection. Computationally,
we will use coarse-grained (CG) molecular dynamics (MD) simulations to characterize the assembly process on
the membrane and to identify a set of models for further refinement through all-atom (AA) MD simulations. This
innovative and integrated approach will not only provide careful validation of the results, but also provide detailed
structural insights into the lipid-protein and protein-protein interactions governing the assembly and budding of
SARS-CoV-2. The protein interfaces of M and N identified in these studies, which will be key for virus assembly
and spread, will inform future drug targeting against SARS-CoV-2 and other coronaviruses.

Public health relevance
Public Health Narrative: SARS-CoV-2 is a coronavirus and causative agent of COVID-19 that has caused a global pandemic pushing healthcare systems to their limits. To date, there is little understanding how coronaviruses such as SARS-CoV-2 utilize the host lipid network to spread from cell to cell. This project brings together a diverse set of researchers to understand assembly, budding and spread of SARS-CoV-2 from human cells, which should in turn identify novel drug targets in the viral life cycle.